Cardiovascular Risk of Non-Opioid Pain Medications

PROJECT SUMMARY
When compared to the general population, U.S. Military Veterans disproportionately experience pain, especially
severe pain. Indeed, pain management is one of the most common reasons Veterans seek medical assistance.
The U.S. Department of Veterans Affairs (VA) and Veterans Health Administration (VHA) have continued to
focus attention on chronic pain management, which has resulted in the implementation of new guidelines and
systems that prioritize non-opioid treatments.
Current pharmacologic alternatives to opioids for chronic pain management include: (1) topical and oral
analgesics such as lidocaine, acetaminophen, and non-steroidal anti-inflammatories (NSAIDs); (2)
antidepressants; (3) anticonvulsants; and (4) muscle relaxants. We and others have defined the cardiovascular
toxicity of NSAIDs and opioid analgesics, but the potential toxicity of other drug classes used to treat chronic
pain remains poorly defined. This is particularly important for three classes of drugs: (1) selective norepinephrine
reuptake inhibitors (SNRIs) antidepressants, (2) antiepileptics, and (3) muscle relaxants. Within each drug class,
duloxetine (SNRI), pregabalin (antiepileptic), and cyclobenzaprine (muscle relaxant) are among the most
frequently prescribed. Usage of these three drugs has generated multiple case reports and raised specific
concerns for increased risk of serious cardiovascular events.
Currently, hundreds of thousands of Veterans are filling prescriptions for these drugs each year, and the use of
non-opioid pain drugs is increasing. Veterans encompass a vulnerable population with high cardiovascular risk
and high rates of chronic pain; thus, they are at higher risk for adverse drug effects. The overwhelming majority
of Veterans with chronic pain do not have cancer or life-threatening illness, which makes the prospect of drug
toxicity from long-term use a particularly important consideration.
Clinical trials play a crucial role in demonstrating treatments' efficacy; however, many drugs have had unforeseen
and serious side effects. Since clinical trials necessarily are limited with regard to generalizability and can be
impractical, pharmacoepidemiologic studies play a critical role in our knowledge about the long-term side effects
of drugs. The proposed pharmacoepidemiologic studies seek to provide critical information about the
cardiovascular risks associated with three widely prescribed non-opioid medications used to treat chronic pain
and frequently prescribed to Veterans in the VA health system. We will use state of the art techniques and a
large database of Veterans to assemble a cohort of patients with chronic non-cancer pain. Aim 1 will define the
risk for serious cardiovascular outcomes in patients taking cyclobenzaprine. Aim 2 will define the risk of serious
cardiovascular events associated with the use of duloxetine. Aim 3 will define the risk of heart failure associated
in patients taking pregabalin. These studies will compare those risks with the risk observed in patients with
chronic pain taking two active comparators: tramadol and celecoxib. Our overarching goal to improve the health
of Veterans and prevent negative side effects makes these studies an excellent fit with the VA mission.

Public health relevance
PROJECT NARRATIVE This study seeks to provide important information regarding medications used to treat Veterans' chronic pain. With growing awareness about the risks associated with the use of opioids, clinicians, researchers, and agencies have increased their emphasis on alternate therapies, including non-opioid medications. Despite strong reasons for concern about the cardiovascular toxicity of three widely-prescribed non-opiates, we know relatively little about their cardiovascular side effects. This knowledge gap is particularly important because pain management is a leading factor for Veterans seeking medical care, and their complex conditions place them at higher risk than the general population. We aim to determine whether these drugs place patients at higher risk for adverse cardiovascular outcomes. Our results will improve understanding of the long-term safety of commonly used drugs, leading to safer treatment of chronic pain among Veterans.